Genomics

The Genomics Shared Resource (GSR) provides a broad spectrum of services and resources designed to
make the state-of-the-art techniques used in DNA sequence and transcript analysis readily available to the
Holden Comprehensive Cancer Center (HCCC) laboratory and clinical research communities. The researchbased services and resources of the GSR include: 1) DNA sequencing, including whole exome sequencing, 2)
custom oligonucleotides, 3) DNA microarrays (Illumina BeadArray system), 4) real-time PCR, 5) molecular
biology computing, and 6) genome, mRNA and single cell sequencing using next-generation sequencing
(NGS) technologies. The GSR also provides access to state-of-the-art informatics including bioinformatics
software and tools, public/local data and databases and computing and machine-learning/artificial intelligence
capabilities. Molecular biology computing personnel work closely with investigators early in the process to
improve study design and assure generation of high-quality data that meets the needs of the investigators.
GSR also continues to evaluate and update services to remain cutting-edge and provide new services needed
and serves HCCC investigators from each of the HCCC programs.

Public health relevance
PROJECT NARRATIVE Not applicable